A mosaic Down syndrome model system comparing isogenic trisomic/disomic cells to unmask trisomy-21 related genomic, epigenomic, and senescence changes acquired across the lifespan

PROJECT SUMMARY
Down syndrome (Ds) has been associated with multiple, co-occurring health and behavioral conditions, as well
as precocious (or accelerated) aging. The results of recent clinical studies are providing a clearer picture of
health outcomes in childhood, adolescence, and early adulthood in people with Ds; yet very little is known about
the cascade of trisomy 21-related biological changes that arise to culminate in the development of co-occurring
conditions. The recent discovery of cytosolic DNA as an “integrator” of changes acquired in somatic cells
provides a new research direction for identifying age- and trisomy 21-related biological alterations. Cells can
acquire cytosolic DNA via micronuclei (MN) formation and extrachromosomal telomere circles (t-circles). A
subset of this cytoplasmic self-DNA is recognized by innate immune surveillance pathways, which, in turn, lead
to increased levels of senescence. We hypothesize that trisomy 21 increases MN levels and telomere attrition,
leading to a perpetuating cycle of senescence and methylation alterations that accumulate/increase in frequency
with age. One powerful approach for discovering trisomy 21-specific alterations is to evaluate biological attributes
in cells from people with mosaicism for trisomy 21 (mDs). One can unmask and quantify trisomy 21-induced
changes by “subtracting” values observed in isogenic disomic cells from those present in trisomic cells (thereby
removing the confounding effects due to total background genetic make-up, as well as environmental influences).
Thus, to identify the impact of a trisomy 21 imbalance on cytosolic DNA pathways, we will longitudinally compare
biological measures in isogenic trisomic versus disomic cells from 65 people with mDs over 3 time points,
(including baseline data, and spanning as much as 30 years of follow-up). To test our study hypothesis, we will
quantify: (1) cytosolic self-DNA via a MN assay; (2) subtelomere/telomere alterations or dysfunction; (3)
senescence patterns and cytokine levels; and (4) DNA methylation patterns. Each of these biological factors will
be analyzed with “state of the art” tools we developed/optimized, which include: chromosome-specific assays for
MN [SKY/FISH MN assay]); novel telomere/subtelomere length assays [Q-FISH & nanomapping]; telomere
dysfunction assays; senescence, transcriptome, and cytokine marker assays; genome-wide studies for DNA
methylation; and bioinformatic modeling. We will also collect/evaluate deep phenotype data. By interrogating
relationships among and between biological measures with phenotypic traits, we will discover their role in
mediating health outcomes. In summary, this longitudinal study of isogenic trisomic/disomic cells will enable us
to “unmask” trisomy 21-associated changes in biological cascades and will provide the first assessment of the
role of cytosolic DNA in health conditions associated with Ds/mDs. By identifying driver/mediator relationships
between biomarkers, we will create new algorithms that will help physicians recognize health conditions at an
earlier age in people with Ds/mDs. Importantly, we will identify new therapeutic targets that could transform our
approach for developing treatments to alleviate symptoms of health conditions acquired by people with mDs/Ds.

Public health relevance
NARRATIVE Down syndrome is associated with many health conditions, including ones that result in developmental problems, as well as disorders that are acquired with aging (such as early onset Alzheimer-like dementia, hearing loss; cataracts; and inflammation-related conditions). The overall goal of this study is to identify biological changes related to cytoplasmic self-DNA that are acquired with age (body cell chromosomal changes, telomere shortening, senescence, and/or epigenetic alterations) as a result of a trisomic imbalance for chromosome 21 in people with mosaic Down syndrome; with the expectation that this knowledge will provide foundational information needed to develop new health screening tests and/or treatments.